Gadgetron Global Network and Intelligence Computing: Clinical Imaging Application Development and Software Infrastructure

The past FY of 2022-2023 saw many development of imaging AI and Gadgetron projects:

a) Imaging foundation model is under development with Gadgetron global network data support.

b) Imaging transformer model is developed to support large training and show impressive capacity to boost image quality, shorten acquisition and improve resolution.

c) Agreements were established with multiple sites to let NHLBI keep and use anonymous data for research purpose and beyond.

d) Invented methods to calibrate models and showed imaging transformer improve SNR without sacrificing spatial resolution.

e) Submit four papers to the CMR 2024.

Sarah M Hooper, Sen Wu, Rhodri H Davies, Anish Bhuva, Erik B Schelbert, James C Moon, Peter Kellman, Hui Xue, Curtis Langlotz, Christopher R. Evaluating semi-supervision methods for medical image segmentation: applications in cardiac magnetic resonance imaging. Journal of Medical Imaging. 2023, 10, 2.

JP Howard, K Chow, L Chacko, M Fontana, GD Cole, P Kellman, H Xue. Automated Inline Myocardial Segmentation of Joint T1 and T2 Mapping Using Deep Learning. Radiology: Artificial Intelligence. 2023, 5, 1.